Differential Gene Expression in Aging-Related Embryonic Development

The Laboratory of Cardiovascular Science is committed to identifying those gene products which are differentially expressed in embryonic development through exploitation of the cardiac developmental model of embryonic stem and embryonic carcinoma cell differentiation. Serial analysis of gene expression (SAGE) yields a quantitative, representative and comprehensive differential gene expression profile. Using several time points in the precise developmental profile of embryonic stem and carcinoma cell differentiation to cardiomyocytes, SAGE analysis has been used to generate a quantitative transcript assessment that has proven to be much more rapid and economical than other techniques. We used an RT-PCR based technique to determine the time points where a number of mesodermal and cardiac-restricted gene products are expressed in in vitro differentiated EC derived cardiomyocytes. Results show that the earliest contractions occur on Day 5.5 of differentiation (3+2.5 or 4+1.5). Some contractile protein genes (beta MHC) are expressed before the third day of differentiation, but we show that a clear induction of expression of alpha MHC and MLC2V starts relatively later (5+0.5 and 3+1 for alpha MHC and MLC2V respectively). GATA-4, a transcription factor involved in the regulation of cardiac contractile protein gene expression is highly present in the earliest stages of differentiation, and form 3+1.5 days of differentiation, its expression is reduced to the level of adult heart tissue. This indicates that this time period corresponds to an early stage of cardiac differentiation. We have now used the protocols of SAGE to analyze expressed sequence profiles during these time periods. A total of 150,354 tags have been sequenced from three P19 EC cell-based libraries (undifferentiated P19 cells, differentiation Days 3+0.5 and 3+3.0). Ten percent of the 43,432 unique tags matched sequences in the NR GenBank database, while more than 30% of the unique tags did not match any known mouse sequence. Temporally-restricted induction or repression of transcripts at each differentiation stage examined was a common feature of the developmental profiles, suggesting that differentiation-specific processes are necessary for pre- and early cardiac development. Analysis of the normalized tag frequency with differentiation revealed significant changes (p<0.01) in expression of 357 gene products, including the known cardiac differentiation factor Thing1 (HAND1). Temporal analysis of the 97 tags that had a greaten than 10-fold change in expression with differentiation revealed four patterns of expression: monotonic-ascending, monotonic-descending, bell-shaped and U-shaped. Transcription factors implicated in cardiac development (e.g., GATA-4, TEF-1, TGF-beta, Hox-7, HAND1) mostly fell in the bell-shaped group, indicating that this profile is relevant for the identification of cardiac regulatory genes. Eight novel transcripts (PST-1 to PST-8), including two with a temporal-restricted profile, were analyzed further. Five of these were present in adult heart, but none were cardiac-restricted. The novel gene products identified in this study provide a framework for the analysis of pre- and early cardiac developmental processes in human and mouse. In these on-going studies, we are now characterizing many of the gene products whose expression was significantly changed in the bell-shaped group to identify cardiac induction/differentiation factors.